Functionally Closed Purification and Elution of Untouched Cells using Cleavable Magnetic Beads with Digital Magnetic Sorting

Project Summary
Isolation of specific and well-defined cell types to produce next generation cellular therapies remains a significant scale up
and scale out challenge for autologous and allogeneic therapies.
Through primary customer interviews of cell therapy developers, we learned there is an unmet need for scalable cell sorting
systems that can isolate rare cell types on multiple markers in production of nuanced cellular therapeutics. With preliminary
studies, we demonstrated that our scalable core technology (digital magnetic sorting) achieves superior rare cell isolation
and can achieve parallelized multitarget sorting to address this need.
In this proposal, we aim to develop a functionally closed, quantitative cell purification system that can isolate rare and
specific cell types based on multiple markers at throughputs conducive for cell therapy manufacturing.

Public health relevance
Project Narrative The goal of this project is to develop a functionally closed, quantitative cell purification system that can isolate rare and specific cell types based on multiple markers at throughputs conducive for cell therapy manufacturing. Current technologies cannot perform rare cell isolation or multitarget sorting at large scale. Our platform can provide a platform for cell therapy manufactures to isolate highly specific cell populations to develop more potent therapies.